Diversity Supplement: Implementation of EMR-Integrated Referrals

ABSTRACT
Background: Stroke disproportionately affects Black adults residing in the buckle of the “stroke belt”, or
rural southeastern United States. The disparities among stroke are partially attribute to structural racism,
or systems that produce inequities among racial groups, such as racial residential segregation.
Segregation creates social and environmental conditions that adversely affect health, which may include
vehicle access. Having access to a vehicle is essential for self-management of stroke risk enabling travel
to health-promoting institutions. Yet, individuals who lack vehicle access tend to be those who are people
of color, poor, and reside in rural areas. The CommunityRx-Cardiovasular Disease (CRx-CVD)
intervention from the Parent R01 generates electronic medical record linked prescriptions to community
resources to meet patients’ health-related social needs with the goal of improving the self-management
of CVD and stroke risk factors. Previous CRx studies have increased patients’ resource self-efficacy, or
confidence in finding community resources, a potential key link to improving self-management of stroke
risk. However, segregation and vehicle inaccessibility could diminish the health promotion efforts of such
novel digital tools.
Methods: The purpose of this longitudinal, convergent mixed methods study is to examine whether
structural racism via segregation as well as community- and individual-level vehicle access 1) are
associated with individual stroke risk and 2) impact resource self-efficacy, a strategy for self-management
of stroke risk factors, among working age (18-64 years) Black adults. Our main hypothesis is structural
racism (i.e., segregation) and lack of community- and individual-level vehicle access will be associated
with lower resource self-efficacy, and less confidence related to self-management of stroke risk. To test
this hypothesis, existing census tract data will be joined to patient data (survey, electronic medical record
data, and interviews) using geocoded addresses. The specific aims of this supplement are:
Aim 1. Examine associations of racial residential segregation (i.e. marker of structural racism), vehicle
access, and individual stroke risk.
Aim 2a. Explore the mediating effect of racial residential segregation (i.e. marker of structural racism)
and vehicle access on the association between resource self-efficacy and individual stroke risk.
Aim 2b. Explore the mediating effect of vehicle access on the association between residential
segregation and individual stroke risk.
Aim 3. Conduct a mixed methods analysis to identify barriers and facilitators to resource self-efficacy
and the subsequent effect on stroke risk in the context of residential segregation and vehicle access.

Public health relevance
PROJECT NARRATIVE Stroke disproportionately disables and prematurely ends the lives of working age (18-64 years) Black adults in the rural southeastern United States. The systemic (i.e. structural racism) factors associated with such racial health disparities must be examined to better tailor healthy lifestyle interventions that use a “whole person” approach to chronic disease self-management, especially in communities of color with high cardiovascular disease and stroke risk.